Administrative Core

PROJECT SUMMARY/ABSTRACT
ADMINISTRATIVE CORE
The central question for the Rocky Mountain Cannabis Research Center (RM-CRC) is the extent to which the
health effects of cannabis products are influenced by the amount or ratio of THC and CBD and how these
effects are mediated by the endocannabinoid system (ECS) and associated lipids. To that end, the RM-CRC
will implement three research Projects, two analytic Cores (Cannabis Research Analytics - CRAC, Data
Harmonization and Analysis - DHAC), and two support Cores (Administrative, Pilot Project). The first Aim of
the Administrative Core is to ensure the efficient and effective administration of the overall Center. To that
end, the Core will oversee the day-to-day financial, personnel, and regulatory activities of the RM-CRC and its
Projects and Cores and ensure that communication between Study Investigators and Core Directors, and
utilization of RM-CRC resources occur in a manner that promotes the highest level of productivity. The Core
will also establish and oversee an Internal Advisory Committee (IAC) and External Advisory Committee (EAC)
to evaluate progress and results, recommend changes, and suggest future directions. The second Aim is to
establish diversity, equity, and inclusion within the RM-CRC. The University of Colorado School of Medicine
and Department of Psychiatry have pledged matching funds of $1,050,000 to assist with this Aim. Finally, the
third Aim of the Core is to establish the RM-CRC as a national resource with an interface to facilitate outreach,
and education. To that end the Core will work with the DHAC to develop and manage an appropriate data
sharing action plan and to interact with investigators outside the RM-CRC who may wish to access RM-
CRC data. The Administrative Core will also field queries regarding other types of affiliations with the RM-
CRC and/or requests to utilize the services of the CRAC as a national resource. Finally, the Core will develop,
implement and manage all RM-CRC retreats, seminars, and other RM-CRC education/outreach activities.